Prospective Cohort Study of Cryptococcosis

DESCRIPTION (provided by applicant): Cryptococcus gattii (Cg) was considered to be a fungal pathogen restricted to tropical and subtropical climates until 1999, when an outbreak caused by a previously unrecognized, hypervirulent strain of a new molecular group (VGIIa) became evident on Vancouver Island (VI), Canada. During the years spanning 1999-2003, the VI incidence of Cg infection in humans exceeded that of historically endemic regions. Since 2004, this outbreak has spread to mainland Canada and to multiple states in the Pacific Northwest U.S. Also, other VG group isolates have caused disease in other non-contiguous states in the U.S., including Hawaii, New Mexico, Rhode Island, Michigan, and Georgia. Mortality rates have exceeded 30%, largely associated with delayed diagnosis and neurologic morbidity. Recognition of this pathogen is important, as preliminary studies suggest variability in antifungal susceptibilities as well as the need for a different clinical approach, given excessive neurologic inflammation associated with central nervous system infection. A large proportion (50%) of patients have no underlying immunosuppressive risk, but early studies suggest that the infection serves as a sentinel for unsuspected adult-acquired immunodeficiency, including deficiencies in specific IgG subtypes and the presence of auto-antibodies to granulocyte macrophage colony stimulating factor (GM CSF). The goal of this proposal is to perform a prospective cohort study that will increase our understanding of this emerging infection. Focus is placed on defining host risks, appropriate management of neurologic complications, and effective antifungal therapies. In Aim 1, we will perform a prospective cohort study, employing an internet-based case report form in an established network of sites led by the global Mycoses Study Group, with site identification facilitated by national and state public health officials. Daa and samples obtained as part of the prospective cohort study will enable sub-studies to evaluate new diagnostics. In Aim 2 a nested case-control study will be performed to evaluate the immunologic correlates of Cg infection and progressive disease in people who are without apparent immunosuppressive conditions. This aim is enabled by detailed studies performed by intramural investigators at the NIH clinical center. This study represents our first concerted effot to describe clinical features of this important emerging outbreak in the U.S. Our long-term goal is to generate the information needed to effectively prevent and treat this infection.

Public health relevance
PUBLIC HEALTH RELEVANCE: A new strain of the fungus Cryptococcus gattii has been recognized and is spreading in different parts of the world, most recently in North America, causing a severe and potentially fatal illness involving the lungs and the brain. We don't know yet how best to treat it, but in this study, we will collect data to help us understand the risks o contracting this infection as well as ways to successfully treat it. In addition, we will determine whether people who lack a particular type of antibody are at increased risk of progressive infection with this fungus. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS One of the most recently emerged infections in North America is that caused by Cryptococcus gattii (Cg). Although this organism historically was known to cause disease in tropical areas of the world, a novel, highly virulent molecular type (VGIIa) appeared in 1999 as a cause of human and veterinary disease in the Pacific Northwest (PNW). The outbreak was first localized to Vancouver Island (VI), British Columbia but it spread geographically. Cg causes disease now in areas of the U.S., with two phenomena: 1. Spread of the outbreak strain and related genotypes (VGIIa-c) in the PNW; and 2. Cg molecular types (VGI, VGIII) in other regions of the U.S., including CA, HI, and states in the Southwest and East. The true toll of infection in the U.S. is not known, as infrequent microbiologic identification and lack of reporting has limited our knowledge. It is critically important to distinguish between Cryptococcus species, as the syndrome caused by Cg is unique compared to that caused by C. neoformans. First, Cg causes more focal pulmonary disease, in different hosts. Many people who develop Cg infection are considered immune-competent and without recognized underlying risks. Clinical outcomes are poor, with mortality approximating 30% [1, 2], and excessive neurologic complications resulting from inflammatory responses. Many people who have been managed in the U.S. and Canada have required aggressive anti-inflammatory (corticosteroid) management for sterile arachnoiditis, and aggressive CSF drainage with shunts. Some Cg strains, especially those of VGII group, exhibit high-level resistance to fluconazole, the historical staple for treatment. Finally, detailed immunologic profiling suggests that Cg infection serves as a sentinel for subclinical immunodeficiency, with people noted to have decreased levels of specific IgG types [3] and others having high levels of anti-granulocyte-macrophage colony stimulating factor (GM- CSF) autoantibodies. Retrospective studies suggest that there are differences in presentation and outcomes between different molecular types (VG) of Cg worldwide; unfortunately we lack the information that we need to establish systematic, data-driven treatment guidelines, and outcomes worldwide remain poor. To develop better preventative and therapeutic strategies, several central questions require immediate attention: 1.What is the natural history of human infections in endemic and non-endemic regions, including clinical courses and long-term follow-up? 2. What are the underlying clinical and immunological factors that dictate risks for infection, and disease? In collaboration with the academic global Mycoses Study Group (MSG), intramural NIH investigators, and the Centers for Disease Control (CDC), we have established the infrastructure for a multi-center web-interfaced prospective cohort study to allow for molecular, immunological, and clinical characterization of cryptococcal disease in people who are not infected with HIV, and established the methods and protocols necessary to perform a detailed nested analysis of immune correlates of disease: Specific Aim 1: To perform a prospective longitudinal cohort study to characterize cryptococcosis in people not infected with HIV. We will perform a prospective cohort study using a global network of clinical investigators. Case reporting will be facilitated by the CDC and state public health system. Patients will be actively consented to enable longitudinal evaluation, and data will be captured using web-based case report forms that focus on clinical risks, therapies and outcomes of infection. Patients will be contacted in 3-month intervals, for up to 2 years. Collection of samples (microbial and clinical) will enable multiple sub-studies focused on understanding risks and diagnostics. Specific Aim 2: To characterize immune correlates of cryptococcosis and progression in people who have no apparent immunosuppressive conditions. Approximately 50% of people who have developed Cg infection in the U.S. have no apparent underlying risks for invasive infection. A nested case-control study will be performed with case patients who "opt-in" for consent to undergo extensive testing of organism-specific cellular (antibody and T cell) responses at the NIH clinical center. Healthy volunteers will be recruited for controls. We hypothesize that subclinical cellular deficiencies, and/or presence of anti-GM-CSF autoantibodies present high risks for invasive Cg disease. Cg-specific T cells, IgG, and anti-GM-CSF autoantibodies will be quantified and compared in healthy people who develop Cg disease, and healthy controls. The relationship between quantitative responses and clinical outcomes will also be assessed longitudinally in cases. Studies are enabled by a unique surveillance system and web-based reporting, assisted by the public health system. Sub-studies will combine both hypothesis-generating and hypothesis-driven investigations, providing both innovation and novelty while assuring that a robust amount of data is obtained. Our long-term goals are to improve diagnostics, understand risks, and determine which factors guide treatment failure, allowing for development of improved algorithms to prevent and treat Cryptococcus disease. 1